Racial Biases in Pain Treatment: Tests of pain-care recommendations, treatment biases, and race perception mechanisms

PROJECT SUMMARY/ABSTRACT
E. Paige Lloyd, PhD is a social psychologist whose ultimate career goal is to use her expertise in intergroup
relations to investigate the social psychological underpinnings of health disparities and create interventions that
reduce treatment disparities and promote equitable care. The research she proposes titled, “Racial biases in
pain treatment: Tests of pain-care recommendations, treatment biases, and the malleability of race perception
processes” addresses gaps in the literature, offers practical insights, and provides a platform for development.
Research: Pain is a prevalent and consequential health concern. However, pain care is not equally distributed;
for example, White Americans receive more aggressive and guideline-directed pain care than Black
Americans. Although there is consistent evidence of pain care disparities, there is no work integrating models
of race perception or experimentally examining the contribution of these processes to pain care decisions. The
overall objective of this research is to identify and attenuate problematic race-perception processes
contributing to racial biases in pain treatment. To test this objective, Dr. Lloyd will pursue the following Specific
Aims: Aim #1: To investigate the presence and pattern of clinician biases in pain care for White, Black, and
multiracial Black/White hypothetical patients, Aim #2: To examine the extent to which person perception
processes are associated with treatment recommendations for hypothetical Black, White, and Black/White
patients, Aim #3: To empirically test a novel intervention designed to attenuate race perception biases. Three
complementary studies employing vignette, standardized patient, and intervention designs will 1) examine pain
care biases across Black, White, and Black/White multiracial hypothetical patients, 2) the race perception
mechanisms that inform treatment recommendations, and 3) potential solutions to biases in race perception.
Training: The proposed career development plan will build upon Dr. Lloyd’s previous training with three
training goals: 1) expand measurement and statistical expertise to encompass assessment of race
categorization and nonverbal biases, 2) gain expertise in the ethics, theory, and methodologies of health
services research relevant to disparities 3) learn about developing and implementing translational
interventions. Dr. Lloyd and her mentorship team propose specific training activities, didactic and experiential,
that will enable her to gain the skills necessary to complete the proposed research and develop as an
independent scientist. This training will be supported by an experienced and successful multidisciplinary team.
Dr. Lloyd’s institution and department, the University of Denver and the Department of Psychology, are
committed to her success and have provided extensive resources to promote her productivity and training.
This award will provide Dr. Lloyd with the training and pilot data required to seek R01 funding, become a
nationally-recognized independent investigator, and make scientific contributions that promote equitable care.

Public health relevance
PROJECT NARRATIVE Race-based pain treatment disparities are well-established, existing across pain types and treatment contexts. Alongside patient-level and system-level factors, clinician-level biases have been implicated in disparate pain care; however, we do not yet understand the specific race-perception mechanisms that may serve as antecedents to biased care, and current intervention strategies have achieved limited success in mitigating bias. The current work tests an integrated account of race perception processes theorized to underlie race disparities in pain care and offers an initial examination of a psychological intervention targeting race perception as a route to more equitable care.